Engineering a lab-on-a-particle platform to measure platelet function

PROJECT SUMMARY
The purpose of the Bold New Bioengineering Research for Heart, Lung, Blood and Sleep Disorder and
Diseases is to support early phases of groundbreaking bioengineering projects that have the potential to
revolutionize diagnostics and treatment. In response to NOSI (NOT-HL-21-024), we propose a
bioengineering research idea that challenges the status quo in platelet function testing, which has been
hampered by low throughput, high variance, and unreliable methods that fail to capture the full complexity
of platelet physiology. The long-term goal of this line of research is to engineer technologies that can
diagnose the spectrum of bleeding disorders at increased specificity, sensitivity, and throughput than is
currently available. The overall objective of this application is to design elastic hydrogel microparticles as
a platform to measure platelet adhesion, activation, aggregation, and contraction. The rationale for this
project focuses on inherited platelet disorders that are challenging to detect using conventional clinical
assays, or lack a specific diagnosis as in the case of many acquired bleeding disorders associated with
acute or chronic inflammation. We will meet our overall objective with two specific aims: 1) Immobilized
particle assay to measure platelet function kinetics; and 2) Suspended particle assay to measure platelet
function equilibrium. We will synthesize peptide-functionalized polyethylene glycol (PEG) particles that
present ligands in a combinatorial manner using microfluidic single and double emulsion approaches. In
Aim 1, the kinetics or speed of platelet adhesion, activation, aggregation, and contraction will be
measured by optical microscopy on immobilized beads in a channel. The equilibrium or strength of these
same platelet subfunctions will be measured in suspension in a well-defined shear flow using a rotational
rheometer. This approach simulates force-dependent platelet function that is regulated by blood flow in
vivo, but with the throughput of a flow cytometer. By creating a platform where each particle serves as an
individual test site and each assay includes thousands of test sites, we aim to improve the reliability and
reproducibility of platelet function testing, as well as identify new patterns of underlying bleeding disorders.
The proposed research is innovative, in our opinion, because it represents the creation of a diagnostic
approach that incorporates four key elements of platelet function—adhesion, aggregation, activation, and
contraction—within a high throughput format via a lab-on-a-particle platform. This contribution will be
significant because it has the potential to improve the lives of people with bleeding disorders by
standardizing diagnostic criteria which is currently undefined.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on developing technologies to diagnose people with abnormal bleeding. Once such technologies have been developed, there is the potential to better define origins of disease and responses to drugs. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to seeking fundamental knowledge about the nature of living systems.